RESPIR. RATE DETERM--AGE-SPECIFIC VARIABILITY &HUMAN OBSERVER RELIABILITY (HUMAN

Determining the optimum method for obtaining respiratory rates in children of various ages and with different respiratory conditions (i.e., with URI, LRI with fever due to non-ARI causes, and healthy cases) would be of great benefit to the World Health Organization (WHO) since WHO recommends uring a respiratory rate of >50 as the best clinical indicatory of LRI.